Optimizing health outcomes by improving measurement of grief after amputation with a health equity approach

Candidate: Dr. Cody McDonald is an Assistant Professor in the Department of Rehabilitation Medicine at the
University of Washington (UW). She completed her MPH and PhD at UW and has been engaged in
rehabilitation-related research since 2014. Dr. McDonald has worked on several federally-funded research
grants, including a randomized crossover trial and multiple outcome measure development studies. She also
collaborates with colleagues at the federally-funded UW Center for Outcomes on Rehabilitation Research. Dr.
McDonald’s research experience includes multiple phases of the translational research process: collecting and
analyzing qualitative and quantitative data; development and application of new outcome measures; preparing
for and implementing randomized crossover trials. Dr. McDonald’s long-term career objectives are to elucidate
grief and emotional health after amputation and understand how grief may impact health outcomes; to develop
measures centered in patient priorities to assess constructs of importance for individuals with impairments; and
to develop and employ strategies for measure development and implementation to improve health equity.
Environment: The UW School of Medicine consistently ranks among the top Medical Schools in the nation in
the U.S. News and World Report for its excellence in research, clinical training programs, and patient care. The
School of Medicine is an international leader in biomedical research, receiving over $500 million in research
funding annually. The Department of Rehabilitation Medicine at the University of Washington has had a strong
commitment to research since its inception. Research, both basic and clinical, is a major component of the
departmental mission. The Department is consistently ranked in the top two in NIH funding and the top three in
overall research funding for all rehabilitation departments.
Research: In the proposed research, I will develop and calibrate a new patient-driven measure to assess grief
after amputation using a health equity approach. This project includes two aims: first to develop a new self-
report measure to assess grief using a health equity approach, and second, to conduct initial calibration of this
new tool. Community-based participatory research methods and principles will be used throughout the
proposed project. A community advisory board will be developed and engaged to inform project decisions. To
develop the measure, I will conduct a literature review of existing grief measures. Next, I will use focus group
and interview discussions with individuals with amputation (with a focus on minoritized groups) and guided by
the diagnostic criteria for prolonged grief disorder and the socioecological model of health. Using existing
measures and qualitative findings, I will develop new items and test them through cognitive interviews. Based
on interview results, I will narrow items to a final item bank. The final item bank will be used to conduct a
national survey of adults with limb amputation. This survey will yield data on the psychometric properties of the
grief measure including initial calibration data and information about how items function within the measure.

Public health relevance
Project Narrative Grief is the natural emotional response that occurs after a traumatic injury such as limb amputation, however, grief after amputation has not been well described, studied, or understood, likely because no outcome measures to assess grief after amputation exist. The goal of this research is to develop a patient-reported outcome measure using community-based participatory methods, modern instrument development techniques, and a health equity approach. The new measure will optimize outcomes and quality of life for individuals with amputation by equitably improving measurement and understanding of the emotional experience of major limb amputation.